Illuminating ER Lumen AMPK Dynamics for Maintaining Vascular Homeostasis via ACE2

Project Summary
Adenosine monophosphate-activated kinase (AMPK) is a master metabolic regulator critical for sensing low
cellular energy states and initiating catabolic activities while also inhibiting anabolic activities.1 It has become
increasingly clear that spatiotemporal regulation of AMPK is key to achieving specificity in AMPK signaling and
fluorescent biosensors have served as powerful tools for monitoring spatiotemporal AMPK activity.2 AMPK helps
maintain vascular homeostasis by phosphorylating different substrates such as angiotensin converting enzyme
2 (ACE2), a transmembrane receptor critical for maintaining blood pressure homeostasis, which is
phosphorylated by AMPK to maintain stability, though where and how this AMPK/ACE2 interaction occurs is
unclear.3 Due to the topology of ACE2 as a type I transmembrane protein, the AMPK/ACE2 interaction would
require AMPK to enter the secretory pathway despite having no secretory signal peptides. In this proposal, we
aim to (1) identify molecular mechanisms underlying the regulation of AMPK in ER lumen and (2) examine the
functional role of ER lumen AMPK activity in ACE2 signaling. In preliminary studies, using an ER lumen-targeted
single-fluorophore excitation ratiometric AMPK activity reporter (ExRai AMPKAR), I found AMPK is active within
the ER lumen and that such activity is dependent upon the upstream kinase CAMKK2. I also showed that
endogenous AMPK is associated with an ER lumen-specific protein, Grp94, using the proximity ligation assay
(PLA). I hypothesize that AMPK is phosphorylated by CAMKK2 prior to its Grp94-mediated translocation into the
ER lumen and will combine biochemical and live-cell assays to test this hypothesis. As part of our second aim, I
found endogenous ACE2 is localized to the ER and that AMPK-phosphomimic ACE2 had enhanced presence at
the plasma membrane versus nonphosphorylatable ACE2. I hypothesize that AMPK phosphorylates ACE2 in the
ER lumen to facilitate its trafficking to the plasma membrane where it functions to maintain vascular homeostasis.
We are now developing an ER lumen AMPK inhibitory peptide to use in ACE2 trafficking and endothelial function
assays. The proposed studies will illuminate a novel AMPK activity site not mechanistically described and will
fortify our understanding of spatial AMPK signaling to inform cardiovascular drug development and therapeutic
strategies, especially for hypertension.

Public health relevance
Project Narrative We are studying a key metabolic signaling molecule, AMPK, and its critical function in cardiovascular health and disease such as facilitating blood pressure maintenance through its interaction with the protein ACE2. While previous work identified that AMPK stabilizes ACE2 to offer cardiovascular benefits, our understanding of where and how this interaction occurs is limited. The work proposed here should lead to a better understanding of AMPK/ACE2 interactions to improve our understanding of blood pressure regulation and dysregulation, which affects millions of adults worldwide every year.